Longitudinal multi-omic biomarkers for neurocognitive decline prior to dementia onset

PROJECT SUMMARY
The major features of Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD) include
elevations in amyloid beta (Aβ) and tau that result in the formation of neuritic plaques, neurofibrillary tangles
and cerebral atrophy. These processes begin decades before the onset of the cognitive deficits that
characterize the early clinical manifestation of AD/ADRD. However, the pathophysiology of AD/ADRD remains
incompletely understood and additional molecular processes may give rise to either Aβ and tau accumulation
or to other neurotoxic processes that have yet to be identified. This proposal will investigate proteomic
biomarkers for cognitive and brain changes in the Lothian Birth Cohort 1936 (LBC1936), one of the best-
characterised longitudinal studies in the world. It will also combine data from other world-class prospective
studies of cognitive and brain aging to create the largest study of protein biomarkers and longitudinal cognitive
and brain changes, prior to clinical ADRD diagnosis, to date. This project aims to measure 7,000
(SomaScan7K) proteins and the already established AD/ADRD biomarkers NfL, p-tau181, p-tau217, GFAP
and Aβ42/Aβ40 in the LBC1936, at ages 73 (N~800), 76 (N~650), 82 (N~400) and 85 (N~300) years. Growth
curve and survival models will be used to test associations between biomarkers and pre-dementia cognitive
decline/brain changes AND hazard of clinically-ascertained dementia. Downstream analyses will be performed
to identify biological pathways associated with cognitive and brain changes in older age. DNA methylation
proxies of proteins (epigenetic scores-EpiScores), which may have more stable longitudinal profiles than the
proteins themselves, will be generated and tested as predictors of cognitive and brain structural changes and
dementia onset. LBC1936 data will be combined with other world-class prospective studies of cognitive and
brain aging (sample N>20,000), and dementia to create the largest study of protein biomarkers and
longitudinal cognitive and brain changes to date. This will allow us to expand our analysis by using the power
of the large sample sizes available through a consortium to generate more precise estimates in a more limited
range of phenotypes that can be used for generating more predictive scores in other cohorts. Blood-based
biomarkers will be validated in brain tissue. Downstream analyses will investigate biological pathways
associated with cognitive and brain changes. Polygenic indices for identified proteins will be created to see if
they predict AD/ADRD in the Alzheimer’s Disease Neuroimaging Initiative (ADNI) cohorts. Mendelian
randomization methods will be used to investigate if levels of proteins identified in the proteomics association
studies cause cognitive decline/brain changes/MCI/AD OR if cognitive decline/brain changes/MCI/AD cause
protein level changes.

Public health relevance
PROJECT NARRATIVE This project will add important large-scale blood proteomic data (~7000 proteins) to the already very well- characterized Lothian Birth Cohort 1936 (LBC1936) for which considerable longitudinal cognitive and brain imaging data have already been collected. It will be the first major endeavor to identify novel blood proteomic biomarkers for the critical changes in cognitive function and brain structure that occur during early phases of disease progression prior to clinical ADRD diagnosis. The data generated will have the potential to contribute to precision medicine and will increase our knowledge of the broad spectrum of biological pathways and networks, beyond the amyloid/tau pathways, that are involved at the very earliest stages of AD.